Genetic and Neuronal Mechanisms that Regulate Zebrafish Sleep

ABSTRACT
Sleep disorders are pervasive, contribute to morbidity in several psychiatric disorders, and cause an annual
economic burden of $100 billion. However, despite its importance for health, the mechanisms that regulate sleep
are poorly understood. We are taking a new approach to this problem by exploiting useful features of zebrafish
to answer an important and basic question: What genetic and neuronal mechanisms regulate sleep? Sleep is
regulated by a homeostatic process that reflects internal cues of sleep need and a circadian process that is
entrained by environmental cues and restricts sleep to the appropriate time. Sleep is also directly and rapidly
regulated by a phenomenon known as masking, in which light induces wake and dark induces sleep in diurnal
animals. Factors that regulate the homeostatic process have been identified, including our recent finding that the
serotonergic raphe promote sleep homeostasis in zebrafish and mice. We also showed that melatonin is
essential for circadian regulation of sleep in zebrafish, and identified a pathway in the brain that regulates
masking. Here we build upon these discoveries to elucidate mechanisms that underlie homeostatic, circadian,
and light-dependent regulation of sleep. We will investigate these mechanisms using zebrafish, a diurnal
vertebrate with several advantages that complement rodent models, using a combination of genetic, optogenetic,
and chemogenetic perturbations coupled with high-throughput behavioral assays and whole-brain neuronal
activity monitoring with single cell resolution. In Project 1, we will identify raphe subsystems that promote sleep
homeostasis, and identify genetic and neuronal circuits that act upstream and downstream of these subsystems
in sleep control. In Project 2, we will identify melatonin receptors that mediate the sleep-promoting function of
melatonin, and also perform a screen to identify neurons through which melatonin implements circadian
regulation of sleep. Project 3 builds on our recent discovery that the hypothalamic neuropeptide prokineticin 2
suppresses both light- and dark-induced masking behavior. Similar to Project 1, we will identify genetic and
neuronal circuits that act upstream and downstream of prokineticin 2 to regulate masking. In Project 4, we will
validate a large number of human sleep disorder candidate genes that were identified by genome-wide
association studies. We will do so by leveraging zebrafish to efficiently and inexpensively generate and test many
mutant lines for sleep phenotypes. We will determine the mechanisms through which validated candidate genes
regulate sleep, and integrate these genes into the pathways identified in Projects 1-3. The homeostatic (Project
1), circadian (Project 2) and light-dependent (Project 3) mechanisms that regulate sleep, as well as the sleep
disorder genes identified in humans and validated in zebrafish (Project 4), are likely to be integrated at multiple
levels to produce either sleep or wakefulness. This research program provides a unified platform to explore
interactions between genes and neurons identified in each project. This will allow us to derive a comprehensive
understanding of mechanisms that regulate sleep, and will set the stage for novel therapies for sleep disorders.

Public health relevance
PROJECT NARRATIVE Despite the importance of sleep for health and the prevalence of sleep disorders, the regulation of sleep remains poorly understood. We will use zebrafish to identify genetic and neuronal mechanisms that mediate homeostatic, circadian and light-dependent regulation of sleep, and to identify genes and mechanisms that underlie human sleep disorders. These studies will likely identify novel targets that may eventually lead to new therapies for sleep disorders.